Investigation of a novel molecular driver of schwannoma nerve sheath tumors

PROJECT SUMMARY: Schwannomas are the most common sporadic nerve sheath tumor which arise from
the Schwann cells that ensheathe and insulate axons of the peripheral nervous system. Schwannomas can
cause significant morbidity depending on location and adjacent structures that are compressed over time,
particularly those involving cranial nerves such as hearing loss for vestibular nerve tumors. Complete resection
can be curative, but may result in permanent nerve injury. Furthermore, resection is not always possible
depending on tumor location that can result in recurrence and progression over time, necessitating additional
surgery or radiation therapy for disease control and symptom management. Thus, there is a pressing clinical
need for more efficacious treatment options. While studying schwannomas arising in the setting of known
predisposition syndromes due to germline mutations involving NF2, LZTR1, and SMARCB1 has shed
substantial light on schwannoma pathogenesis, the molecular drivers responsible for sporadic schwannomas
have not been fully resolved to date. Through genomic profiling studies, we discovered that 22/77 (29%) of
sporadic schwannomas lack alterations in known schwannoma-associated genes and instead harbor recurrent
in-frame insertions or deletions in SOX10, which encodes a transcription factor responsible for controlling
Schwann cell differentiation. These insertions/deletions are uniformly somatic (tumor-acquired) and localize at
the C-terminal end of the HMG box domain responsible for DNA binding. Our preliminary analysis has revealed
that schwannomas harboring SOX10 indel mutations often occur along paraspinal and non-vestibular cranial
nerves and have high local recurrence rates. Based on our identification of recurrent SOX10 indel mutations
within the DNA binding domain, we hypothesize these mutations are likely to drive schwannoma development
through altered chromatin binding and transcriptional reprogramming that blocks terminal differentiation of
immature Schwann cells resulting in a persistent progenitor-like state. To test this hypothesis, we propose
three aims utilizing our unique cohort of clinically annotated and molecularly-genotyped human schwannoma
tumor specimens, primary human schwannoma cultures and Schwann cell models with wildtype or tumor-
derived mutant SOX10 alleles, and a conditional Sox10flox-K172_Y173dup knock-in mutant mouse strain we have
generated. In Aim #1, we will perform multi-omic profiling to determine whether SOX10 mutation defines a
unique subtype of schwannoma with distinct histopathologic, transcriptomic, epigenomic, and cellular features.
In Aim #2, we will evaluate whether tumor-derived SOX10 mutations result in altered chromatin binding and
transcriptional reprogramming. In Aim #3, we will investigate whether SOX10 indel mutations are sufficient and
necessary to drive schwannoma growth and explore potential therapeutic vulnerabilities of SOX10 mutant
schwannomas. Together, these studies aim to reveal fundamental properties of Schwann cell differentiation
and pinpoint the tumorigenic mechanism of a substantial fraction of clinically aggressive schwannomas.

Public health relevance
PROJECT NARRATIVE Schwannomas are the most common nerve sheath tumor which arise from the myelinating Schwann cells of the peripheral nervous system and can cause severe morbidity given their stereotypic intracranial and paraspinal locations. We have discovered that a large subset of schwannomas are defined by somatic in-frame indel-type mutations in the SOX10 transcription factor gene that all cluster at the end of the HMG box DNA binding domain. This proposal aims to investigate the tumorigenic mechanism by which these novel SOX10 mutations drive schwannoma formation and may potentially create a unique therapeutic vulnerability for affected patients.